Administrative and Data Management Core

ABSTRACT – ADMINISTRATIVE AND DATA MANAGEMENT CORE
The Administrative Core of the Stanford Brain Metastasis Consortium (BMC) is structured to enhance efficiency,
quality, and productivity while promoting integrated and effective collaboration and communication among
Consortium participants, network partners, our local community, cancer networks, and the public in general.
BMC’s Administrative Core aims to minimize the administrative burden of Consortium activities and services,
centralize statistical consultation (study design and data interpretation), cement integration of projects through
regular meetings, communicate accomplishments to the community via Patient Advocates, and encourage
metrics-driven continuous improvement of all Consortium functions.
We have unified brain and cancer experts in the singular goal of improving our understanding and treatment of
brain metastases. To accomplish the above goal, we have: (1) designed an organizational structure that supports
scientists in our integrated Projects, enhancing efficiency and productivity within both the BMC and greater
Stanford University network; (2) established policies and practices that ensure accurate, data-based self-
evaluation for continuous improvement, and developed communication channels with scientists, patients, and
companies most likely to benefit from and build upon our results; (3) created a seed grant program driven by the
underlying goals of quality, equity, innovation, efficiency, and effectiveness.
In summary, the Administrative and Data Management Core will provide fully integrative administrative services
for the management, communications, coordination, and financial administration of the BMC MetNet Center. The
Core will ensure productive collaborations through efficient management, active reflection, and strong
communication, leveraging the expert administrative and financial management resources of Stanford
University, ensuring Stanford Brain Metastasis Consortium’s generation of outstanding, high impact research.